MOLECULAR RESOURCES FACILITY ENHANCEMENT

This proposal requests funds for the acquisition of instruments to augment the MOLECULAR RESOURCES CORE FACILITY at the University of Rochester. Specifically, gradient HPLC systems, oligonucleotide synthesizers, and preparative ultracentrifuges are required to enhance our present and highly used protein purification and nucleic acid core laboratories. This request is supported by a primary user group of THIRTY-ONE investigators and additionally new faculty who comprise a secondary user group. Appropriate institutional support has been committed for technical assistance, construction of new core laboratory facilities, and purchase of required supporting equipment. The facility is centrally located in the medical center and easily accessed by faculty and personnel in all of the Medical School departments, and is also used as the core facility for researchers in the dept. of Biology. The MOLECULAR RESOURCES CORE i.s staffed by trained technical personnel, and each component is under the guidance of a faculty member who is an expert in the area. A facility advisory committee headed by Dr. Abraham, and comprised of Dr. Barbara Iglewski (chair of Microbiology), Dr. Martin Gorovsky (chair of Biology) and Dr. Fred Sherman (chair of Biochemistry), monitors the use and functioning of the facility. The Molecular Resources Core has served its intended function of forming an active center for researchers in the medical center and University departments and has thus far admirably fulfilled its intended function.